Ubiquitination, Intestinal Homeostasis and Cancer

Abstract
Adult intestinal tissues are maintained in a normal functional state despite rapidly proliferating and
differentiating intestinal epithelial cell populations that replenish the epithelium layer every 6-7 days. Intestinal
epithelial cells reside in close association with both adaptive and innate immune cells of the gut. A reciprocal
and dynamic dialogue among these components maintains intestinal homeostasis and is mediated in part by
paracrine cytokine and interleukin networks. Intestinal inflammation predisposes intestinal epithelial cells (IEC)
to malignant transformation via incompletely understood mechanisms. We have generated a novel knock-in
mouse line that spontaneously develops perturbed IEC differentiation, gut elongation, and have a high
susceptibility to colon cancer. These mice provide us with a unique opportunity to discover the key
inflammatory mediators that regulate intestinal homeostasis and drive IEC transformation. Using
transcriptomic, proteomic, genetic epistasis and cellular approaches, our preliminary data implicate selected
immune cytokines in these processes.

Public health relevance
Project Narrative Under normal conditions, epithelial cells reside in close association with immune cells in the intestine and a reciprocal dialogue among these components maintains intestinal homeostasis. Disruption of this homeostatic state can lead to chronic intestinal inflammation and increased risk for colorectal cancer. Our studies aim to arrive at a mechanistic understanding of how A20, also known as TNFAIP3, preserves normal intestinal differentiation and protects against colitis associated cancer.